Early Adversity and Drug Use Vulnerability Among Low Income Rural Children: Testing a Neuro-ecological Model of Resilience

Project Summary
The influence of broader community contexts on children’s neurocognitive development and risk for
downstream drug misuse is significant. The focus of this proposal is on low-income children who reside in rural
Georgia. Being poor in the rural South is particularly challenging for families. Emerging research suggests that
rural vs. urban poverty is characterized by distinct risk and protective factors that have unique effects on
children’s neural and socioemotional development. These differences underscore the unique contextual risk
and protective factors that affect the development of drug use vulnerability among rural youth. Informed by an
ecological developmental neuroscience perspective, we purport that neural markers of vulnerability cannot be
understood in isolation from children’s experience of their ecological contexts. The proposed study is among
the first to integrate neural assessments with multidimensional assessments of environmental stressors and
protective processes in rural communities and begins following children at age 7 during a sensitive
developmental period for life-course-persistent effects on drug use vulnerability.
Our core premise posits that the efficiency of cognitive control systems (cognitive control networks [CCN])
in modulating socioemotional systems (emotion, reward, and salience networks [ERSN]) is a mechanism
linking rural children’s exposure to adversity to their drug use vulnerabilities. We consider the multidimensional
nature of adversity and specify environmental experiences associated with threat, deprivation, and
unpredictability. However, considerable individual differences exist in the pathway linking adversity to drug use
vulnerability, a product of children’s exposure to family, peer, school, and community protective processes.
We propose to recruit 265 low-income, rural children (age 7) and their primary caregivers into a prospective
cohort study (following children from ages 7 to 10). Children will participate in fMRI scans to assess CCN
modulation of the ERSN. To assess exposure to adversity and social-ecological protective factors, we will
obtain rich multi-level information that can be used to test the following aims: 1) the influence of childhood
adversity on neural risk mechanisms, 2) the indirect influence of adversity on drug use vulnerability via neural
risk mechanisms, and 3) the moderating influence of family, peer, school, and community protective factors on
the links between childhood adversity neural risk as well as between neural risk and drug use vulnerabilities.
Multi-level research that effectively connects rural contexts, neuroimaging, and behavioral data is critical for
advancing the precision and specificity of developmental models of drug use resilience for this population.

Public health relevance
Project Narrative Despite the risks conferred by SES-related stress, most low-income, rural children will not develop drug use problems—a phenomenon known as resilience. However, little is known regarding the influence of contextual protective factors in the indirect link between childhood adversity and drug use vulnerability among rural children. Thus, we propose to investigate the protective effects of rural context on neural risk processes associated with drug use vulnerability versus resilience among rural children (ages 7-10 years) to better inform the design and implementation of substance use prevention programs.